Targeting TREM2 AD/ADRD risk and immunometabolism in human microglia

Project Summary
Traumatic brain injury (TBI) and Alzheimer’s disease (AD) cause long-term disability and dementia that
afflict millions of individuals. Both TBI and hypomorphic variants of TREM2, a gene exclusively expressed by
microglia in the brain, increase spontaneous AD risk. High Mobility Group Box 1 (HMGB1) protein is a protein
that increases extracellularly with age and following TBI that initiates pro-inflammatory signaling in microglia, the
innate immune cells of the brain. This proposal will test the central hypothesis that idebenone restores Aβ
phagocytosis capacity and the baseline and HMGB1-reactive transcriptomic signatures of TREM2-deficient
human microglia by rescuing mitochondrial bioenergetic function. TREM2 is required for homeostatic functions
of microglia, including their phagocytic capacity for clearing amyloid-β (Aβ) aggregates linked to AD pathology.
However, because deficient TREM2 signaling is only a risk factor, lifetime environmental factors, which may
include TBI and age-associated changes, are required for AD manifestation. Metabolic alterations in response
to exogenous cues rewire how various immune cell types, including microglia, interact with their environment.
The primary goals of this proposal are to: i) elucidate site(s) of mitochondrial respiratory chain impairment in
human induced pluripotent stem cell (iPSC)-derived microglia-like cells that are TREM2 signaling-deficient, ii)
determine whether the clinically safe compound idebenone rescues mitochondrial bioenergetic function, the
transcriptional response to aging/TBI-relevant HMGB1 stimulation, or impaired Aβ phagocytosis in human
TREM2-deficient microglia-like cells (hereafter referred to simply as microglia), iii) begin to evaluate individual
human variability in male and female microglial responses to TBI- and AD-relevant inflammatory stimulation, and
iv) begin to evaluate individual variability in the ability of human microglia to enzymatically reduce idebenone to
its active form, idebenol. These goals logically build on the lab’s previous lines of investigation by evaluating TBI-
relevant microglial immune responses in tandem with a genetic AD risk factor in human cells and testing whether
a clinically safe mitochondria-targeted intervention mitigates immunometabolic “programming” deficits relevant
to AD and AD-related dementias (ADRD). Aim 1 will test the predictions that the mitochondrial defect(s) of
TREM2 deficient iPSC-derived microglia occur upstream of respiratory chain Complex III and can be rescued by
idebenone. Aim 2 will test the predictions that idebenone normalizes both the baseline and HMGB1-stimulated
TREM2-deficient human microglial transcriptomic signatures and the rate of phagocytic Aβ clearance. Our
studies will determine specific underlying mechanism(s) of mitochondrial bioenergetics deficits in human
microglia with deficient TREM2 signaling, potentially revealing novel intervention strategies to forestall AD
development due to genetic risk or environmental factors like TBI. In addition, our studies will begin to address
how individual genetic variability influences the use of idebenone as a treatment strategy.

Public health relevance
Narrative Traumatic brain injury (TBI) and Alzheimer’s disease (AD) are major causes of long-term disability and dementia that afflict millions of individuals. Both TBI and TREM2 gene variants increase the risk of late-onset Alzheimer’s disease. In this proposal, we will determine whether the clinically safe compound idebenone can rescue mitochondrial impairments caused by deficient TREM2 signaling in human induced pluripotent stem cell- derived microglial cells. We will also evaluate whether it can restore the ability of the microglia to remove Aβ aggregates in the absence and presence of the TBI- and aging-relevant pro-inflammatory molecule HMGB1.